Preliminary Functional Studies of an Understudied NDD Gene in Mice

Project Summary/Abstract
Neurodevelopmental disorders are common, debilitating disorders including autism, intellectual disability, and
perhaps even schizophrenia. Recent genetic findings have identified mutations in multiple genes in various
cellular pathways as genetic causes of rare neurodevelopmental disorders including autism spectrum
disorders, intellectual disability, and others. This proposal will characterize a novel genetic mouse model,
already generated by our laboratory and breeding in our laboratory, to delineate the function of a relatively
understudied disease gene in the brain. Specifically, the proposal will be on a gene implicated in a well-defined
neurodevelopmental disorder. We propose to obtain preliminary behavioral data in this mouse model on
multiple ID-related, ASD-related, and control behavioral tasks. In parallel, we will obtain preliminary single
nucleus RNA-seq transcriptomics data and perform preliminary analyses while also examining a specific
chromatin modification that we predict will be altered in the genetic mutant mouse model. These unbiased,
preliminary, experiments will identify novel downstream targets in mammalian brain, elucidate behavioral
outcome measures for future studies, and generate new hypotheses anticipated to lead to future potential
therapeutic strategies.

Public health relevance
Project Narrative It is critical to better understand genetic causes of human neurodevelopmental disorders such as autism, intellectual disability, and other rare syndromes and to use animal models of such causes to identify potential treatments. This 1-year R03 proposal capitalizes on significant progress in creating a novel animal model deleting an understudied gene for a neurodevelopmental disorder that will allow us to rapidly advance the field. Preliminary characterization of this new model at both the molecular and behavioral levels will provide important data for future studies including final outcome measures such as behaviors in the mouse model along with hypothesis-generating studies of what downstream genes are altered in a cell-type-specific manner, thereby allowing future studies aimed at correcting altered brain function in the hope of treating behavioral symptoms in both the model and in patients.